Mutant Mouse Resource and Research Center (MMRRC) at UC Davis

ABSTRACT: Overall Section
The Mutant Mouse Resource and Research Center (MMRRC) is the nation’s premier mutant mouse archive
and distribution repository system. The MMRRC was established by the NIH beginning in 1999 to ensure the
preservation, dissemination, and development of scientifically valuable mutant mouse strains and data
generated by research scientists. Today, the MMRRC plays a key role in supporting rigor and reproducibility of
experimental results using mouse models in biomedical research. The MMRRC was constituted as a trans-
national consortium of four regionally-distributed Centers each hosting an archive and distribution repository,
one of which is located at UC Davis (MMRRC-UCD), and an Informatics Coordination and Service Center
(ICSC), also located at UC Davis. In coordination with other members of the MMRRC consortium, this grant
application seeks continuing support for the MMRRC-UCD to continue to serve the needs of the nation’s
biomedical research community by ensuring access to, and optimizing utilization of, transgenic, knockout and
other genetically modified mutant mice and related biomaterials (germplasm, embryonic stem (ES) cells,
hybridomas, mouse tissues), services, and technologies. In coordination with the other Centers, the MMRRC-
UCD shall import, verify, maintain, and distribute mutant mice, gene-targeted ES cells, murine hybridoma cell
lines, and germplasm of genetically unique mice that are evaluated as useful and beneficial for contemporary
translational biomedical research. The MMRRC-UCD shall also adopt consortium operating principles to
provide consultation, technical assistance, and genomic and other resources to assist investigators create,
modify, recover, and study genetically-altered mice for applied and translational research in numerous
scientific areas, including cancer, neurodegenerative, neurosensory, metabolic, musculoskeletal, reproductive,
developmental, genetic, and other diseases. In addition, in response to recommendations by the EAC to the
consortium, the MMRRC-UCD shall commit funding to directly to assist the ICSC with increasing submissions
of and orders for new mouse models from the research community. Finally, the MMRRC-UCD has presented
to and sought approval from the other Center PIs on a resource-related research project designed to develop a
new, reliable, and reproducible oocyte vitrification and cryorecovery protocol for use throughout the
consortium. Working within the consortium, the MMRRC-UCD will continue to develop and refine
improvements to technologies that add scientific value to submitted mutant mouse strains and operations of
the MMRRC consortium. In this way, the MMRRC-UCD will participate in the consortium’s goal to preserve,
protect, quality control, and distribute mouse models and provide services for a modest fee upon request to
research scientists and investigators across the nation and around the globe. Through surveys and feedback
from our users, discussions with our MMRRC consortium colleagues and NIH Program representatives, and
engagement with the MMRRC External Advisory Committee (EAC) of experts, the MMRRC-UCD shall
emphasize activities to be an active and engaged member of the MMRRC consortium and to enhance services
to users among the biomedical research community for years to come.

Public health relevance
PROJECT NARRATIVE: Overall Section The Mutant Mouse Resource and Research Center (MMRRC) consortium consists of 4 individual Centers and an Informatics, Customer Service, and Coordination (ICSC) Center that together serve as the premier mutant mouse repository system for the United States. The MMRRC at the University of California Davis (MMRRC- UCD) is a founding member of the consortium, and has developed the largest archive, fulfilled the most orders, and served the most number of investigators of all the Centers. The MMRRC-UCD is an active and engaged participant in all consortium activities, including implementing agreed-to standard operating procedures and guidelines, coordinating outreach and marketing with the ICSC and the other Centers, participates in regularly scheduled meetings of the MMRRC Steering Committee, Annual Meetings, and meetings with the MMRRC consortium External Advisory Board (EAB). The MMRRC-UCD also contributes the outcomes of its resource- related research (cryopreservation, gene targeting, microbiome analysis, phenotyping, etc) with the other consortium partners. Over the next 5 years, the MMRRC-UCD will continue to take a leading role in the actions and activities of the consortium, including assisting the ICSC with increasing submissions and orders for mutant mouse strains from the research community.